Vet-LIRN antimicrobial resistance surveillance through collection of AMR data and whole genome sequencing of isolates from Canadian provinces

Project Summary/Abstract
As a part of the FDA Veterinary Laboratory Information Response Network (Vet-LIRN)
cooperative agreement, Animal Health Laboratory (AHL) will continue supporting Vet-
LIRN’s Antimicrobial Resistance-Whole Genome Sequencing (AMR-WGS) program.
Through already established process we will continue with routine collection of clinical
bacterial isolates in source labs, provide AMR data for all isolates collected and ship
isolates quarterly to the core lab for WGS. Every month the source labs will collect 4
isolates of Escherichia coli and 4 isolates of Staphylococcus pseudintermedius from dogs
as well as four Salmonella enterica isolates from any animal species. In addition, eight
isolates from the other (OTH) category (Klebsiella spp., Enterobacter spp., Enterococcus
spp., Pseudomonas spp., etc.) will be collected following the sampling plan provided by
Vet-LIRN. Antimicrobial susceptibility data will be provided for all of these isolates.
Furthermore, four Campylobacter spp. and four aquatic bacterial pathogens will be
collected monthly if available. Metadata for all collected isolates as well as the
susceptibility data will be provided to Vet-LIRN on a quarterly basis.
To ensure harmonization of methodology and support surge capacity testing for Vet-LIRN
during large-scale emergency events, AHL will continue using MiSeq to do WGS of
bacterial isolate following protocols provided by Vet-LIRN. Based on Vet-LIRN quarterly
selection, a subgroup of the bacterial isolates will be sequenced, and their metadata and
sequence information will be submitted to the National Center for Biotechnology
Information (NCBI) database for scientific community use. AHL will also continue
participating in proficiency testing provided by Vet-LIRN and GenomeTrakr.

Public health relevance
Project narrative This work will continue to increase the capacity and capability of veterinary diagnostic laboratories including AHL through use of harmonized analytical methods to combat antimicrobial resistance, and to respond swiftly to animal and human foodborne illness outbreaks. It will continue to monitor antimicrobial susceptibility trends in bacterial isolates recovered from companion animals across the USA and Canada through susceptibility data collection and WGS. By doing this work, AHL and other veterinary laboratories are building their capacity for timely responses to outbreaks, while at the same time providing a significant amount of data to the general scientific community through National Center for Biotechnology Information (NCBI) for additional scientific work (i.e., monitoring antimicrobial resistance trends, exploring virulence factors, tracing outbreak sources, etc.).